Rapid Motion-Robust and Easy-to-Use Dynamic Contrast-Enhanced MRI for Liver Perfusion Quantification

Project Summary
The broad objective of this application is to develop a rapid motion-robust and easy-to-use dynamic contrast-
enhanced magnetic resonance imaging (DCE-MRI) framework for liver perfusion quantification and to evaluate
its performance in quantitative assessment of hepatocellular carcinoma (HCC), the most prevalent primary
malignancy in the liver. Dynamic contrast-enhanced magnetic resonance imaging (DCE-MRI) using
gadolinium-based contrast agents is currently a cornerstone for identifying and characterizing hepatic lesions,
including HCC. However, the current clinical use of liver DCE-MRI is limited to visual assessment of the pattern
of perfusion in 3-4 multiphasic images (arterial, venous and delayed phases), and these images are routinely
acquired during multiple breath holds. DCE-MRI also has the potential for quantitative assessment of perfusion
kinetics, which can provide a deeper insight into the tumor microenvironment for non-invasive characterization
of different histological features of the tumor, such as tumor angiogenesis and aggressiveness. This is
particularly relevant for HCC, which is typically diagnosed based on imaging without pathological confirmation
from invasive biopsy. Unfortunately, conventional liver perfusion MRI techniques suffer from a number of
important limitations that restrict its clinical implementation, including (1) slow imaging speed, (2) limited
spatiotemporal resolution, (3) sensitivity to motion artifacts, and (4) time-consuming quantitative perfusion
analysis. Meanwhile, the need for pre-contrast T1 mapping to convert MR signal to gadolinium concentration
further complicates the already-cumbersome imaging workflow. These challenges and underlying complexity
have all led to non-reproducible performance of liver perfusion MRI and have significantly diminished its
ultimate clinical utility. In this project, we propose to develop new rapid MRI techniques combining novel
motion-robust sampling strategies and advanced reconstruction models to address these challenges. The new
imaging techniques will enable motion-robust 3D T1 mapping with whole-liver coverage for efficient estimation
of contrast concentration and free-breathing DCE-MRI of the liver with high spatiotemporal resolution. We will
also incorporate state-of-the-art methods in deep learning to further improve imaging performance, to reduce
reconstruction time, and to substantially simplify perfusion quantification. These new technical developments
will be integrated into a new liver perfusion MRI framework, which will be translated into the clinical setting for
assessment of HCC in an exploratory clinical study. The overall hypothesis is that with the new imaging
framework developed in the project, robust high spatiotemporal resolution perfusion MRI of the liver can be
achieved under free breathing, and absolute quantification of liver perfusion can be performed without user-
interaction. Given the rapidly rising incidence and substantial burden of HCC in the United States, successful
completion of this project would enable significant progress towards improved characterization and
management of HCC and other liver diseases with high clinical impact.

Public health relevance
Project Narrative The objective of this application is to develop and evaluate a rapid motion-robust and easy-to-use dynamic contrast-enhanced magnetic resonance imaging (DCE-MRI) framework for liver perfusion quantification. This new imaging framework is expected to promote the utilization, efficacy and clinical translation of liver perfusion MRI for improved management of hepatocellular carcinoma (HCC) and other diseases of high clinical impact.